DESIGNED METAL BINDING SITES OF 43C9 SINGLE CHAIN ANTIBODY

Catalytic antibodies were developed with metal binding regions, as mimics of metallo enzymes. ESEEM was used to identify and quantify the number of imidazoles bound in various mutant proteins.